Role of Sox18 in neurovascular dysfunction in Alzheimer's disease

PROJECT SUMMARY
Cerebral blood vessels are critical to deliver blood, containing oxygen and nutrients, to every neuron
and glial cell in the brain. In addition, the endothelial cells comprising central nervous system blood
vessels possess unique properties, termed the blood-brain barrier (BBB), that allow them to tightly
regulate the movement of ions, molecules, and cells between the blood and the brain, thus, tightly
regulating the extracellular environment of the brain. Studies have indicated that neurovascular
dysfunction, including hypoperfusion and BBB dysfunction, may be an important component of
Alzheimer’s disease pathogenesis. This vascular dysfunction could lead to accumulation waste
products such as amyloid, leakage of serum components to the brain, and increased neuroinflammation,
all of which could have important impacts on the neurodegeneration that is observed in patients with
Alzheimer’s disease. Despite the potential importance of neurovascular dysfunction, very little is known
about the molecular changes to cerebral blood vessels in patients with Alzheimer’s disease, and how
these changes may affect neurovascular function and the progression of Alzheimer’s disease pathology.
We have performed proteomics on blood vessels isolated from human patients with Alzheimer’s
disease and from age and sex matched controls. Interestingly, we found downregulation of pathways
involved in angiogenesis and barrier formation, which may account for the hypoperfusion and BBB
dysfunction, respectively, observed in Alzheimer’s disease patients. The proteomic data also showed
robust downregulation of the transcription factor SOX18 in the blood vessels of patients with
Alzheimer’s disease. We further used mice models to downregulate Sox18 expression in brain
endothelial cells and found very similar changes to those found in Alzheimer’s disease patients,
including a downregulation of angiogenesis and barrier formation pathways. Therefore, we hypothesize
that downregulation of SOX18 in brain endothelial cells is key to the neurovascular dysfunction
observed in patients with Alzheimer’s disease. In this grant we will first examine the role of Sox18 in
modulating neurovascular function in mice, including angiogenesis and barrier formation. We will then
use human induced pluripotent stem cell models of the BBB to identify the molecular mechanisms by
which SOX18 regulates neurovascular function. We will then determine whether modulating Sox18
expression can alter the disease course in multiple mouse models of Alzheimer’s disease. These
experiments will allow us to understand the role of SOX18 in neurovascular function, and determine
whether targeting SOX18 could limit the pathogenesis of Alzheimer’s disease.

Public health relevance
PROJECT NARRATIVE Dysfunction of cerebral blood vessels is observed in patients with Alzheimer’s disease, and is thought to be an important component in the pathogenesis and progression of the disease. Despite the importance, very little is known about the molecular mechanisms that lead to neurovascular dysfunction and how these can be targeted to limit the progression of Alzheimer’s disease. Here we test the hypothesis that downregulation of the transcription factor Sox18 is an important mediator of neurovascular dysfunction in Alzheimer’s disease, and thereby determine whether this molecule is a potential therapeutic target for limiting the progression of Alzheimer’s disease.